ST1-RTA IMMUNOTOXIN FOR UNRELATED DONOR BONE MARROW TRANSPLANTS

This is a Phase I/II trial of the use of a monoclonal F(ab')2 fragment conjugated to the A chain of ricin. The monoclonal antibody recognizes the CD5 cell surface protein. T cells that are CD5+ internalize the immunotoxin and are killed, thus reducing the number of infused T cells and reducing the risk of GvHD. We are assessing the therapy for rate of engraftment and rate of development of graft vs. host disease.